Research Training for Veterinary Students

SUMMARY
Veterinary specialists with biomedical and comparative research skills are essential for ensuring One Health
and meeting the mission of the NIH; however, a shortage of veterinarians with biomedical research training has
resulted in gaps in research expertise diversity and a lack of proficiency in research animal model development
in the biomedical workforce. The College of Veterinary Medicine (CVM) at Iowa State University (ISU) has an
enduring history of educating veterinarians, many of whom have entered careers in biomedical research. Our
incoming (2018-19) student class is historically our largest (127 students) and most diverse, and is augmented
by additional students from cooperative educational agreements with the University of Nebraska at Lincoln
Veterinary and Biomedical Sciences (UNL-DVM, 27 students) and Tuskegee University (1 student) leading to a
substantial pool of students for recruitment as T35-funded scholars in our Summer Scholar Research Program
(SSRP). Additionally, despite escalating competition in biomedical research funding, awards from various
federal (eg. NIH, USDA, DOD, FDA), industry, stakeholder, and foundation sources to ISU CVM researchers,
including mentors on this T35 proposal, have increased from $13 million to almost $18 million in the past 3
years. This combination of prospective scholars, mentor research accomplishments, and collaboration with
local, regional, and national institutions, along with demonstrated historical achievement of our SSRP speaks
to the potential for our success in training the next generation of veterinarian researchers with assistance from
this T35 training program.
The overall goal of the T35-supported scholar training project and the SSRP at ISU CVM is to increase the
workforce in One Health by empowering veterinary medical students with interest and skills in biomedical
research with a 13-week training program during summer periods to enhance their understanding of key
aspects of, and provide a pathway into, the field of biomedical research. In this new application, we outline a
plan for achieving our goals by demonstrating the success of our faculty mentor pool, establishing a matching
process of mentors with scholars that is intended to identify students most likely to pursue a career in research
that supports the NIH mission, conducting a training program that includes fruitful laboratory experiences
guided by engaged and qualified mentors in state-of-the-art facilities, and enhancing the impact and diversity of
the program. The work proposed in this application will help to provide a pipeline of exceptional veterinary
students guided into a career path in biomedical research and will aid in reducing the critical shortage of
veterinarian researchers needed to address One Health challenges.

Public health relevance
PROJECT NARRATIVE. There is a need to increase the number of veterinarians trained in biomedical research to support the nation’s health. Since 1991 Iowa State University’s (ISU) College of Veterinary Medicine (CVM) has established a summer scholar research program (SSRP) that has trained over 513 veterinary medical students, with 105 of these students funded by prior T35 training grants. Award of this new T35 application will support the ISU CVM goals of training veterinary students with biomedical research interest in laboratories that support the mission of the NIH.